Temporal and Metabolic Regulation of Restimulation-Induced Cell Death (RICD) in Human T Cells

PROJECT SUMMARY/ABSTRACT PI: Snow, Andrew L.
The healthy immune system depends upon a balance of proliferation and death of white
blood cells, including B and T lymphocytes, to contain and eliminate infectious pathogens
effectively without doing unintended damage to “self” tissues. I have a long-standing interest in
elucidating the molecular mechanisms responsible for maintaining immune homeostasis in
humans, focusing on B and T cells. One way that activated T cells are instructed to die occurs
upon repeated engagement of the T cell receptor (TCR); a process known as restimulation-
induced cell death (RICD). This self-regulatory death program protects against excessive
expansion of T cells as an immune response unfolds. The long-term objective of my research
program is to define specific biochemical signals that convert the TCR signal from
proliferation and survival to death, which remain incompletely understood.
Our research is informed in part by investigating human immune disorders, caused by
single gene defects, that result in dysregulated immune homeostasis. We previously discovered
a novel RICD defect in T cells from patients with X-linked lymphoproliferative disease (XLP),
which lack expression of SLAM-associated protein (SAP). SAP is required for proper RICD in
normal T cells. Using a variety of genetic and biochemical approaches, we illuminated a
previously unrecognized network of biochemical signals connecting SAP, NTB-A, and key
kinases (e.g. LCK, DGKa), phosphatases (SHP-1), and transcription factors (FOXP3) that
regulate TCR signaling and ultimately govern RICD sensitivity in human conventional and
regulatory T cells. However, we also learned that several other signaling molecules independent
of this network control RICD. Moreover, we discovered that dynamic changes in cellular
metabolism also play a major role. Over the next five years, our research will be focused on
determining if and how specific co-inhibitory receptors, transcriptional regulators, and metabolic
circuits “tune” RICD susceptibility over the entire human T cell response, including early stages
of rapid T cell proliferation. Elucidating these critical signaling events will improve our basic
understanding of abnormal T cell signaling and cell death in patients with immune disorders
beyond XLP. Understanding these molecular interactions should offer new therapeutic targets to
control T cell responses by manipulating RICD sensitivity, which could be applied to numerous
clinical contexts in which culling excess T cells (e.g. autoimmunity, lymphoproliferative disease)
or boosting T cell responses (e.g. infection, vaccination, cancer) could help ameliorate disease.

Public health relevance
PROJECT NARRATIVE The proposed research will elucidate new biochemical and metabolic checkpoints involved in regulating T cell death, focusing on the function of several molecules with potential diagnostic and therapeutic value in regulating the magnitude of a given T cell response. Defining these pathways will help us better understand, predict, and potentially control immune responses in situations where increasing or decreasing T cell numbers would be beneficial. Therefore, this research is broadly relevant to public health and numerous clinical settings in which the potency of the T cell-directed immune response is directly related to disease severity and outcome.